Understanding the role of CsrA in Acinetobacter baumannii survival and infection

Abstract
Acinetobacter baumannii is an opportunistic pathogen that causes serious infections
which are very difficult to treat due to multidrug resistance. The majority of these infections
occur in hospitalized, critically ill individuals, and spread through the hospital environment is a
major concern for this pathogen. We developed a screen to identify genes that support the
survival of A. baumannii on dry surfaces, since this ability likely facilitates A. baumannii’s
spread. One of the genes we identified encodes the regulatory protein CsrA. This regulator is
important for controlling metabolism and virulence in other bacterial species, and as we began
to study the function of CsrA in A. baumannii, we found that it also appeared to be critical for
host-associated growth. This has provided a great opportunity to discover novel genes and
determinants involved in A. baumannii virulence and spread by further investigating the
regulatory function of CsrA in this organism. The goals of this proposal are: 1) To determine
the specific functions needed for host-associated growth by examining role of CsrA in controlling
A. baumannii metabolism; and 2) To identify direct regulatory targets of CsrA in order to
understand how it influences A. baumannii growth and environmental survival. The long-term
objectives of this research are to identify potential targets for the development of new
treatments for A. baumannii infections, and to gain a better understanding of the mechanisms
through which A. baumannii persists in the nosocomial environment with the goal of developing
new interventions to curb its spread in hospitals.

Public health relevance
Project Narrative Acinetobacter baumannii is a major source of hospital-acquired infections worldwide and is considered an urgent threat due to its extremely high rates of multi-drug resistance. We have discovered that the regulatory protein CsrA is essential for A. baumannii to grow within a host, and is involved in survival in the environment. The goals of this research are to understand why CsrA is needed for A. baumannii to utilize host-derived nutrients, and how CsrA supports its survival on surfaces, with the goal of identifying targets that can be exploited to combat A. baumannii infections or limit its spread in hospitals.